Research Training in Experimental Immunology

This is a multi-disciplinary program for “Research Training in Experimental Immunology” at the University of Michigan Medical School (UMMS). Faculty preceptors with interests in immunology and immunological mechanisms of disease are selected from 12 UMMS departments, as well as the College of Pharmacy, Dentistry, and the Veteran’s Affairs hospital. Our senior preceptors direct active, highly regarded laboratories with exemplary records of scientific impact and funding. These preceptors have outstanding records in mentoring graduate students and postdoctoral fellows. In addition, we have added highly regarded new investigators and will ensure they have ample guidance in becoming accomplished mentors themselves. The Immunology T32 Training Program (ITTP) is directed by Dr. Bethany Moore who has 12 years of experience directing the ITTP. The co-Director is Dr. Malini Raghavan, former Director of the Graduate Program in Immunology (GPI) at UMMS. Dr. Shannon Carty is the Assistant Director for the ITTP and current GPI Director. Drs. Moore, Raghavan and Carty will work closely with the ITTP Executive Committee, internal and external advisors, and the GPI Graduate Student Affairs Committee to advise trainees, monitor curriculum and resolve any issues. The ITTP will continue to sponsor: 1) a weekly seminar for students and postdoctoral fellows to present works-in progress, 2) a visiting professor monthly seminar where invited guest speakers present their research and interact with program faculty and trainees, 3) ITTP Research Colloquium courses which provide in depth training in experimental immunology methods and translational immunology, 4) short courses for deeper learning in trainee-chosen topics and 5) programmatic activities including a journal club, annual retreat, peer mentoring, career development and networking opportunities for our trainees. The ITTP also provides training in responsible conduct and rigor and transparency in research and is committed to recruiting and training outstanding mentees to build a talented pool of researchers for the next generation. Support is requested for 5 predoctoral and 3 postdoctoral trainees, an increase to reflect the growth in the immunology community at Michigan, growth in the GPI enrollment, growth in our ITTP training faculty and increased demand for training in this field. This ITTP program has been essential to the formation of the GPI at the University of Michigan and our success is best measured by the outstanding publication and presentation records of our recent trainees and the excellent postdoctoral, academic and industry positions they earn as they progress. Importantly, this is the only T32-supported program specifically addressing immunology research at the University of Michigan.

Public health relevance
Immunology is the study of the body’s immune system and how it responds in states of health and disease. Many human conditions involve alterations of the normal function of the immune system including cancer, autoimmune diseases, infectious diseases, and transplantation. The purpose of this training grant is to instruct the next generation of scientists in the critical thinking and technical skills necessary to provide mechanistic insights into how the immune system functions, and how to manipulate the host immune response to the benefit of human health.